GREAT: Collaborative Genomic Initiative between Prairie View A&M and Texas A&M Universities

Project Summary/Abstract
This GREAT Program will develop genomics opportunities for students at Prairie View A&M
University (PVAMU) through a collaboration with Texas A&M University (TAMU) TAMU is one of
the largest Hispanic-serving institutions in the United States with over 4000 students majoring in
biomedical or biological sciences, and PVAMU is an HBCU comprised of 86% black students and
>50% first generation students. While these institutions are separated by 40 miles, there have
historically been few collaborations in the area of biomedical science. This program will develop
a Course-based undergraduate Research Experience (CURE) focusing on using genomic and
bioinformatic approaches to predict the function of unannotated genes. The CURE will be co-
taught by PVAMU and TAMU faculty. Over the summer students will participate in research in a
TAMU genomics lab. These research opportunities will be complemented by workshops,
networking events, and other training opportunities. Together, the proposed program will foster
critical thinking, self-empowerment, and provides students the skills and training necessary to
enter PhD programs in genomics, or to enter the workforce in a genomics-related area. Taken
together, this program will strengthen genomics programming at PVAMU, develop ties between
the two universities, and promote diversity in genomic sciences.

Public health relevance
Project Narrative There is a need to promote diversity in genomics research, and opportunities for students an non-doctoral granting institutions. This proposal represents a collaboration between Prairie View A&M and Texas A&M to implement a genomics curriculum at Prairie View that includes a specialized series of courses and workshops aimed at promoting critical thinking, while immersing students in independent genomics research at Texas A&M.